Investigating pathways of hippocampal synaptic funtion: potential implications for Alzheimer's disease

Project Summary
Alzheimer's Disease (AD) is a neurodegenerative disease affecting millions of people around the globe.
AD pathology includes neuronal cell death, synaptic dysfunction, and corresponding behavioral deficits.
However, the molecular basis underlying AD pathologies remains unclear. Glycerophosphodiester
phosphodiesterase 2 (GDE2) is a member of a six-transmembrane protein family that releases
glycosylphosphatidylinositol (GPI)-anchored proteins from the cell surface. In the developing nervous system,
GDE2 promotes neuronal differentiation in the central nervous system (CNS) using its GPI-anchor cleavage
mechanism. During aging the loss of GDE2 leads to AD-like phenotypes, including Aβ production, synaptic
protein loss, and neurodegeneration. In human AD brain tissue, GDE2 aberrantly accumulates intracellularly
compared to healthy control brains, suggesting that GDE2 dysfunction could contribute to AD pathophysiology.
GDE2 mediates its functions in regulating Aβ production and synaptic protein loss via regulation of surface
expression of the GPI-anchored protein RECK (reversion-inducing cysteine-rich protein with Kazal motifs).
RECK is a potent inhibitor of metalloproteases and is recently implicated in canonical Wnt signaling. Increased
expression of membrane RECK leads to a decrease in synaptic proteins that is independent of Aβ production
and levels of membrane RECK are highly elevated in AD patient brain. The guiding hypothesis of this proposal
is that GDE2 regulates synaptic function through the cleavage of RECK and that dysfunction of this pathway
contributes to AD synaptic pathology and cognitive changes. I will test this hypothesis through a multi-pronged
approach that will utilize electrophysiological, behavioral, and molecular approaches. In Aim 1, I will assess the
requirement for GDE2 in pre- and post-synaptic function in mice. In Aim 2, I will perform a variety of behavioral
experiments testing cognition to define corresponding behavioral abnormalities in mice lacking GDE2. Finally, in
Aim 3, I will probe the molecular mechanism through which GDE2 and RECK act to affect synaptic biology.
These experiments will expand our knowledge of the role GDE2 plays in synaptic biology and could potentially
help us better understand the mechanistic basis of AD pathologies. This research will be performed in a highly
collaborative environment, where I will have numerous opportunities to receive quality mentorship and training,
to develop my written and presentation skills, and to grow as a mentor and teacher to more junior scientists.
Overall, the Kirschstein-NRSA grant will support both my research aimed at discovering the synaptic biology
underlying neurodegeneration and my development as an independent scientist.

Public health relevance
Project Narrative Disruption of the GDE2 pathway mimics neurodegenerative and synaptic changes observed in Alzheimer's Disease (AD). Proposed studies will use a three-pronged experimental approach employing electrophysiological, behavioral, and molecular techniques to determine how this pathway affects synaptic function and behavior. Outcomes have potential to provide deeper insight into underlying mechanisms of pathologies associated with AD that in the long-term may aid in the design of mechanism-based therapies for AD.